Relationships between immunosenescence, brain aging biomarkers, and cognition across nonhuman primate species of differing lifespans

Project Summary
The world’s population is aging, which brings about huge scientific challenges. Since the biological process of
aging is by far the greatest risk factor for most chronic diseases, understanding the molecular and cellular
mechanisms by which aging leads to these conditions is of vital importance to increase the health span of older
adults. Aging results in several structural and functional changes in the immune system and is clinically
associated with increases in the frequency and severity of infectious diseases and incidences of cancer,
chronic in inflammatory disorders, and autoimmunity. This general dysregulation in immune system function is
referred to as immunesenescence. Immunosenescence is a multifactorial and dynamic complex phenomenon,
which is shown as a lengthy adjusting and remodeled process existing in immune system during lifespan.
However, the mechanisms under-lying age-associated dysregulated immunity are still incompletely
understood. This proposal investigates a new perspective on immune cell markers and function with age
across NHP species with differing lifespans. In addition, we will examine the relationship between immune
aging and neurodegenerative biomarkers and cognition and compare these relationships across the NHP
species. These studies will help determine the role the immune system plays in longevity, neurodegeneration
and cognitive decline, which may allow researchers to develop and test immuno-restorative approaches with
the goal of improving longevity in humans.

Public health relevance
Project Narrative The proposed studies aim to develop squirrel monkeys, rhesus monkeys, baboons, and chimpanzees as a well-defined immunological model to target immunosenescence. We plan to investigate the relationship between immunosenescence and both neurodegeneration and cognition across these species with differing lifespans. The differences within and between species may elucidate differences within human populations and can lead to the development of interventions aimed toward improving longevity.